Simulation and Education Tool for Physical Examinations of Orthopedic Pathologies

Project Summary/Abstract
The proposed project focuses on creating a simulation system that provides hands-on skills training of
musculoskeletal, soft tissue, and ligament function for medical and health science students. Significance:
Musculoskeletal (MSK) disorders are the most frequent chronic health problems in the United States. Despite
this reality, education in the prevention, diagnosis, and management of MSK disorders and injuries is
underrepresented in entry level training and postgraduate residency programs leaving primary care providers
underprepared. Multiple studies have confirmed that students lack competency in this domain, having difficulty
performing and interpreting the results of MSK examinations, leading to reduced patient outcomes.
Hypothesis: We hypothesize that the creation and availability of a new simulation system can address this
problem by supporting enhanced learning interactions and increasing knowledge transfer for clinical education.
Specific Aims: A Fast-Track project is proposed where the Phase I aims will be to: 1) Consult with expert
advisory panel and perform final independent evaluation, 2) Prototype knee joint mannequin
materials/mechanical design, and 3) Develop simulation electronics and functionality. If the Phase I meets its
transition criteria of success the follow-on Phase II program will: 1) Collect expert feedback on design and
educational utility, 2) Perform additional skeletal/joint engineering and implement a suite of simulation curricula,
and 3) Validate the system utility through human subject testing and expert evaluation.

Public health relevance
Project Narrative Musculoskeletal (MSK) disorders are among the most prevalent chronic conditions, and a leading cause of global disability and pain. Multiple studies have confirmed that medical students lack competency and training opportunities in this domain and therefore have difficulty performing and interpreting the results of MSK physical examinations which can lead to reduced patient outcomes. Inadequate foundational competence in MSK medicine at an early level of training increases the potential for diagnostic and management errors for future physicians.